Profiling immune cells in aged lung tumor initiation

Project Summary
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-
CA-23-045. The immune system can control tumor growth and shape tumor immunogenicity through the
process of cancer immunoediting, which results in the selection of tumor cell variants that can resist,
avoid, or suppress the anti-tumor immune response and leads to outgrowth of clinically apparent tumors.
Studying the impact of age on immunoediting in the cell type that gives rise to the most common type of
lung cancer is critical to understanding the early stages of tumorigenesis. The predominant cell-of-origin
in lung adenocarcinoma is the alveolar type 2 cells (AT2 cells), a progenitor cell population in the distal
lung. In the first year of the parental U01 studies, we demonstrated that aged AT2 cells exhibit defects in
self-renewal, exhibited by decreased organoid formation in culture and impaired ability to repair alveolar
cell injury in vivo. We also established a genetically engineered mouse model (GEMM) of lung
adenocarcinoma in young and aged mice and identified altered immune cell proportions and cytokines
in aged vs. young tumors. In this supplement, we seek to uncover changes in immune cells in the aged
milieu that may influence AT2 cell functions and define alterations in immune cells that may contribute to
increased tumorigenesis during aging. We investigate these questions in two specific aims: Aim 1: To
assess age-related gene regulation changes in lung lymphocytes and interacting lung epithelial
progenitors. We will 1a) use multiparameter flow cytometry to determine age-related compositional
changes of lung epithelium and immune cells and 1b) single cell sequencing to identify age-related
differences in interactions between immune cells and lung epithelial progenitors at homeostasis. Aim 2:
To define the changes in young vs. aged immune cell populations in the GEMM model of lung
adenocarcinoma. We will 1a) define the immune cell populations altered by age in the TME vs. periphery
using flow cytometry and 1b) dissect single cell transcriptional programs in immune cells from tumors
from young vs. aged mice. This supplement will bring together the expertise of the Haigis and Kim labs
in the parental U01 with the expertise of the Sharpe lab in cancer immunology to identify immune cells
that are perturbed with age, and begin to understand how aging impacts cell populations critical to
immune surveillance and tumorigenesis in vivo. The proposed studies will create a single-cell atlas of
young vs. aged lung at homeostasis and immune cell populations in young vs. aged lung tumors, laying
the groundwork for future studies aimed at elucidating mechanisms of diminished anti-tumor control with
age.

Public health relevance
Project Narrative Aging is a primary risk factor for lung cancer, which accounts for the largest cause of cancer deaths. The immune system provides critical anti-tumor defenses that decline with age. This supplement will use new models generated in the parent U01 to investigate how immune cell profiles change with age in the lung at homeostasis and during lung tumorigenesis.